Cooperative Modulation of Piezo Channels

SUMMARY
Mechanosensitive PIEZO channels sense various forms of mechanical deformations within cells
and tissues. In the cardiovascular system, these proteins are essential to detect blood and lymph
flow, blood pressure, and cardiac contractions. PIEZO1 dysfunctions are associated with various
cardiovascular pathologies including hypertension, xerocytosis, dilated cardiomyopathy, and
lymphedema. Understanding how these proteins activate in the native cellular context is needed
to better understand how mechanical sensations are perceived, and how these diseases emerge
and could be treated more effectively. At the molecular level, PIEZO channels possess a non-
planar bowl-like structure that creates a curvature in the surrounding membrane, known as
“PIEZO membrane footprint”. Mechanical forces that stretch or flatten the PIEZO footprint
promote a flattened channel conformation thought to be associated with an open channel. When
multiple channels diffuse at a high density in a membrane at rest, their large footprints are
predicted to frequently collide. This proposal tests the hypothesis that such collisions remodel
adjacent PIEZO footprints, promoting cooperative interactions that favor channel clustering and
modulation of channel activity. In Aim1, we use multi-scale molecular dynamics simulations to
study the energetics and dynamics of footprint-footprint interactions in large membranes. In Aim2,
we use high-speed single molecule Ca2+ imaging to map the mobility and activity of endogenous
PIEZO1 channels expressed at the surface of endothelial cells derived from human induced
pluripotent stem cells. This will allow us to examine cooperativity between neighboring channels
under physiological conditions. In Aim3, we use high-resolution patch clamp electrophysiology to
precisely quantify cooperativity by comparing the distributions of multi-channel open probabilities
to binomial distributions expected for independent channels. If successful, this project will
establish PIEZO1 cooperativity as a potential mechanism to contextually regulate
mechanotransduction signaling, enhancing our understanding of its role in cardiovascular health
and disease.

Public health relevance
PROJECT NARRATIVE PIEZO1, an important molecular sensor in our cells, plays a crucial role in detecting mechanical forces, and its malfunction has been implicated in several human diseases. PIEZO1 has a distinctive “cup” shape when closed. When the surrounding cell membrane is stretched, the cup flattens and the central pore opens, allowing ions to pass through. Here, to gain a better understanding of PIEZO1 functioning, we investigate how its unique cup shape influences the functioning and interactions of neighboring PIEZO1 sensors.